Investigating the Role of CD40-Induced NEMO modifications in NF-kB signaling

PROJECT SUMMARY CD40 is a surface signaling molecule in the tumor necrosis factor receptor family that is typically expressed on B cells and other antigen-presenting immune cells, but has also been found on tumor cells and thus is implicated in the development of various cancers. One pathway central to CD40 signaling is the nuclear factor kappa B (NF-κB) pathway, which is frequently dysregulated in cancers and has been shown to activate genes associated with cell proliferation, inflammation, angiogenesis, tumor promotion, metastasis, and suppression of apoptosis. The goal of this project is to provide a novel approach to study regulation of CD40-induced NF-κB activation through post-translational modification of NEMO, the NF-κB essential modulator, which may ultimately be used to identify new drug targets and/or strategies to improve upon current methods of cancer therapies. We have recently found that the mutation of two putative NEMO modification sites, 270 and 302, termed NEMO-DK, attenuate NF-κB signaling to affect CD40-mediated B-cell functions in a mouse model. The following specific aims will address the central hypothesis that CD40-induced NEMO post-translational modification(s) play a critical physiological role in mediating NF-κB activation in the course of CD40 signal transduction: 1) Elucidate the role of NEMO post-translational modifications in CD40-induced activation of NF- κB; 2) Assess the biological impact of the NEMO-DK mutation in the context of CD40 signaling. The first aim will be accomplished using in vitro cell-based studies in primary mouse splenic B cells and cell line model systems to identify the CD40-induced NEMO modifications involving lysine residues 270 and/or 302 and assess the impact that mutation of either or both sites have on CD40-induced NF-κB activation. The second goal will be achieved using a NEMO-DK knock-in mouse model to study in vivo B cell function, specifically NF- κB target gene expression, CD40-induced cell proliferation and survival, and antigen-specific immunoglobulin class switch recombination, germinal center formation, and memory B cell formation. Fulfillment of these aims will extend our knowledge of CD40 signaling mechanisms that activate NF-κB, contribute new tools and resources to propagate future research in this field with broader applications potentially in future drug screening of new compounds, and provide necessary insights into cancers and other malignancies exhibiting aberrant CD40 signaling that will facilitate development of better treatments and therapies.

Public health relevance
PROJECT NARRATIVE CD40 is a surface signaling molecule that is typically expressed on B cells and other antigen-presenting immune cells, but has also been found on tumor cells and thus has been implicated in the development of various cancers as well as autoimmune diseases. One pathway frequently deregulated in CD40-related malignancies is the NF-κB pathway, which has been shown to drive cell proliferation and growth conditions amenable for tumor development. The proposed research provides a novel approach to study regulation of CD40-induced NF-κB activation through post-translational modification of NEMO, the NF-κB Essential Modulator, which may ultimately identify new drug targets and/or strategies to improve upon current methods of treatments and therapies. __SpecificAimsTextDelimiter__ SPECIFIC AIMS CD40, a member of the tumor necrosis factor (TNF) receptor family, plays a crucial and multifaceted role in humoral immunity primarily through its expression on B cells and influence over B cell biology. Upon interaction with its natural ligand CD40L found on activated T cells, CD40 activates multiple signaling pathways to stimulate B cell activation, proliferation, and survival as well as germinal center formation, immunoglobulin class switch recombination, affinity maturation, and differentiation of naïve B cells into plasma and memory B cells. As a result, dysregulation of CD40 signaling has serious ramifications and has been linked to malignancies such as B cell lymphomas and autoimmune diseases. In cancer, the importance of CD40 signaling is highlighted by the fact that the oncogene LMP1, produced by the Epstein-Barr virus, mimics CD40 signaling mechanisms to promote an amplified and sustained signal for tumor cell growth and survival. Under these conditions of constitutive CD40 signaling, continuous NF-κB activation is thought to be the predominant signaling pathway driving B cell proliferation and survival, which can then facilitate transformation into tumor cells. Therefore, expanding our knowledge of the mechanisms through which CD40 activates NF-κB signaling will greatly contribute to understanding its role in promoting cellular transformation and cancer. CD40 stimulates both the canonical and non-canonical pathways of NF-κB activation. Although these two pathways have long been considered to signal independently of the other, our group has previously shown that in B cells, canonical NF-κB signaling activates gene transcripts of components necessary for noncanonical NF- κB signaling15. We have recently generated a transgenic mouse harboring two lysine to arginine point mutations in the NF-κB Essential Modulator (NEMO), a key regulator of canonical NF-κB activation, that exhibit defects in several CD40 signaling-related processes, such as impaired formation of antigen-specific memory B cells, defective proliferation of CD40-stimulated splenic B cells, and attenuated activation of NF-κB in CD40- stimulated splenic B cells. These sites of NEMO double lysine (NEMO-DK) mutation at residues 270 and 302 have previously been shown in our lab to be required for DNA damage-induced sumoylation and ubiquitination of NEMO, which facilitate NF-κB activation in response to double strand breaks17. Additionally, CD40 stimulation has previously been shown in the literature to induce NEMO ubiquitination in mouse splenic B cells18. However, the site(s) of NEMO ubiquitination and its relevance to NF-κB signaling and to CD40- mediated B cell biology are currently unknown. We have found that the NEMO-DK mutation attenuates NF-κB signaling to affect B-cell functions in a mouse model. Therefore, I hypothesize that CD40-induced NEMO ubiquitination involving lysine residues 270 and/or 302 acts as an important modulatory mechanism of NF-κB activation that is physiologically required for proper immune cell function and differentiation. My hypothesis will be tested through investigation of the following proposed aims: Aim 1. Elucidate the role of NEMO post-translational modification in CD40-induced activation of NF-κB a. Determine the impact of NEMO-DK mutation on CD40-induced NEMO modification and NF- κB signaling b. Investigate the site-specific requirement of NEMO modification for CD40 signaling of NF-κB Aim 2. Assess the biological impact of NEMO-DK mutation in the context of CD40 signaling a. Investigate the impact of NEMO-DK mutation on CD40-induced NF-κB gene transcription and corresponding protein production b. Evaluate the biological defect of NEMO-DK mice in CD40 signaling-associated processes Fulfillment of these aims will extend our knowledge of CD40 signaling by elucidating a novel and physiologically relevant mechanism for the post-translational modification of NEMO in CD40-induced activation of NF-κB. This information will provide insights into cancers and other malignancies exhibiting aberrant CD40 signaling that may ultimately provide new strategies and/or targets for the development of therapies modulating the NF-κB pathway.